Aldosterone/mineralocorticoid receptor responses to biologic sex and salt intake: Role of Lysine Specific Demethylase 1 (LSD1)

In the past two decades, the roles of aldosterone (Aldo) and the mineralocorticoid receptor (MR) in human
disease have expanded to documenting their dysregulation in a variety of chronic diseases in addition to
hypertension (HTN). Common to all: increased salt intake exacerbates the disease. Thus, Aldo/MR dysfunction
is common in our liberal salt-consuming society and may be present in as many as 10% of apparently healthy
individuals and ~ 16% of individuals with mild HTN. Thus, therapeutic agents have been developed to either
block the MR or the last step in Aldo biosynthesis. However, implementation of specific, personalized therapy to
treat Aldo/MR mediated subtypes of common diseases is still underdeveloped. There are at least two major
gaps in our knowledge that are preventing the achievement of this goal: 1) limited understanding of the
mechanisms that underly the Aldo/MR dysregulation in the presence of a liberal sodium (Na+) diet; and 2) the
confounding effects of biologic sex.
To address these gaps, we propose that Lysine Specific Demethylase 1 (LSD1) is a major regulator of Aldo/MR
expression with salt and sex. LSD1 is an epigenetic, histone-modifying enzyme and plays a critical role in altering
chromatin structure, thus modulating transcription complexes access to DNA. LSD1 acts on histone H3 lysine 4
(H3K4) as a transcription co-repressor or – in conjunction with estrogen/androgen receptors (ER/AR) – at H3
lysine 9 (H3K9) as a transcription co-activator. We recently reported that LSD1 levels in mice are decreased by
dietary salt; LSD1 deficiency (LSD1+/-) in mice associates with lower Aldo but overactive MR. Further, aging in
conjunction with Na+ loading yields a sexual dimorphism in LSD1+/- mice: in male (but not female) mice aging on
a high salt diet induces increases in plasma volume, BP and albuminuria. In addition, Zona Glomerulosa (ZG)
enzymes in the Aldo biosynthetic pathway also display sex-dependent changes in LSD1+/- mice.
These results have led to our overall hypothesis: LSD1 deficiency via its altered actions of histone H3K4
and H3K9 sites causes defects in the dietary Na+ mediated regulation of Aldo biosynthesis and MR
activity, leading to cardio-renal damage in a sex-specific fashion. To assess this hypothesis and the
mechanisms underlying the interactions between LSD1 and Aldo/MR pathways, we will document that LSD1
acts at H3K9 to modulate the Aldo biosynthetic pathway (Aim 1) or at H3K4 for the renal/vascular MR pathway
(Aim 2), respectively. Aim 3 will establish that sex hormones modulate the aging-induced phenotype in LSD1
deficient mice, with ovarian hormones acting as protectors against, and testosterone as a promotor of damage.
Accomplishing these objectives will advance our understanding of the LSD1-mediated mechanisms underlying
the changes in the ALDO synthesis pathway. With this mechanistic understanding, focused clinical studies in
individuals with LSD1 gene variants will be possible leading to genetically defined, sex- and diet-specific
preventive measures for dysfunctional ALDO secretion.

Public health relevance
Project Narrative LSD1 is a protein that regulates whether DNA can be used for making proteins that control the levels of aldosterone and its receptor. Variations in the gene for LSD1 in individuals of African descent and mice with decreased LSD1 levels seem to make them more likely to develop a dysfunctional aldosterone. This project will help us understand the mechanism by which LSD1 modifies aldosterone and its receptor.